Cell and Molecular Imaging Core

Abstract
The Cell and Molecular Imaging (CMI) Core of COBRE Phase 3 strives to maintain its leadership in molecular,
cellular, and animal imaging technologies, furthering our understanding of tumor growth, progression,
metastasis, and therapeutic responses. As a central resource, the CMI Core offers expertise, consultation, and
advanced imaging tools to cancer researchers, pilot project leaders (PPLs), and investigators in Oklahoma.
Under the guidance of Dr. Rajagopal Ramesh, a distinguished expert in cancer research specializing in small
animal in vivo image analysis, and co-director Dr. Ji Hee Ha, a specialist in cell and molecular imaging, the CMI
Core continues to drive scientific innovation. The key core capabilities include:
1. Precision Study Design and Assistance: The CMI Core collaborates closely with investigators, providing
personalized guidance in experimental design and cellular/tissue analysis. Our commitment to one-on-one
consultations ensures that research studies are meticulously planned and executed.
2. Access to Molecularly Tagged Cancer Cells: The Core offers pre-labeled or custom-labeled cancer cells
for molecular and cellular image analysis. This invaluable resource minimizes experimental variability,
fostering research rigor and reliability.
3. Multi-platform Imaging Resources: The CMI Core houses state-of-the-art imaging systems that empower
researchers to conduct in-depth image analysis of cancer cells. From real-time monitoring of disease
dynamics in live animals to gaining 3D anatomical insights, the Core provides a comprehensive suite of tools.
A diverse array of tools including a high-content imaging system, microarray scanner, and various
microscopes, enables comprehensive exploration of molecular and cellular imaging of cancer cells and
tissues in vitro as well as in vivo across multiple dimensions.
Through ongoing staff training, we ensure the Core remains adept at the latest software updates and emerging
imaging techniques. A strategic business plan guides the Core in securing financial stability and seamless
integration into the SCC Research Core Network by the conclusion of COBRE Phase 3.